Vanderbilt Interdisciplinary Training Program in Alzheimer's Disease

The proposed T32 program will provide interdisciplinary, translational research training for pre-doctoral
students and post-doctoral fellows in Alzheimer's disease (AD) and related neurodegenerative disorders.
Leveraging the rich institutional resources of Vanderbilt University and interdisciplinary research strengths of
the training faculty, the program will position the next generation of basic, translational, and clinical scientists to
advance toward independence while making major contributions to the understanding of AD and its
intersection with neurodegeneration and cerebrovascular disease. Through individualized mentorship,
integrated curriculum, and involvement in cutting-edge research, the program will emphasize basic science
and clinical fundamentals of AD and dementia focusing on (a) cellular stress responses and mechanisms of
neuroprotection, (b) hemodynamic and neurovascular mechanisms of injury, (c) cellular regulation and
membrane protein function, (d) mechanisms of memory function and dysfunction, (e) discovery and evaluation
of therapeutic targets, and (f) clinical manifestations of disease. Trainees will develop essential research skills
and professional skills for building a successful career along with a deep appreciation for the responsible
conduct of research. Participation in a high quality interdisciplinary research experience will synthesize the
trainee's knowledge base, research and professional skill set, and appreciation of research ethics. Each
trainee's individualized training plan will be augmented by additional institutional or programmatic didactics and
resources to foster academic excellence and scientific innovation during these early, formative periods of
professional development.

Public health relevance
The prevalence of Alzheimer's disease (AD) is rising dramatically as the population ages, with 13.8 million Americans expected to have AD by 2050. There is a pressing need to prepare basic and clinical scientists with cutting-edge, interdisciplinary research training to foster innovative research advances that address the complex, overlapping pathological processes underlying this growing public health issue.